Mitochondrial Biogenesis in Health and Disease

Project Summary
This proposal is to purchase the Amersham ImageQuant 800 biomolecular imager. by the R35GM118141-
NIGMS-funded investigator Dr. Antoni Barrientos, Ph.D., Professor of Neurology and Biochemistry & Molecular
Biology at the University of Miami Miller School of Medicine (UMMSM). ImageQuant™ 800 systems are a new
generation of highly sensitive and robust charge-coupled device (CCD) imagers for capture of high-quality
images in life science applications. This new range of systems is ideal for chemiluminescence, fluorescence,
and colorimetric imaging of a wide variety of samples, including gels, membrane blots, multiwell plates, and petri
dishes. Improved optics along with the new SNOW™ (signal-to-noise optimization watch) detection mode allows
users to increase both sensitivity and image quality. The system combines an intuitive control software along
with ImageQuant CONNECT software, a connection tool which allows access to the imager from remote
locations over the network. This instrument will allow us to reduce the volume of X-ray films being used in the
lab, and most importantly to increase our versatility, accuracy and experimental rigor.

Public health relevance
Project Narrative The goal of the original MIRA award R35GM118141 is to develop a program aiming to understand the biogenesis of mitochondrial membranes. Disorders arising from impaired mitochondrial OXPHOS function or mitochondrial gene expression, including protein synthesis, result in a variety of pathologies including encephalomyopathies and cardiomyopathies. Identifying and characterizing factors required for OXPHOS enzyme assembly, mitoribosome biogenesis and translation, and the pathways in which they act is a prerequisite towards understanding the molecular basis of these disorders. This proposal is for the purchase of the Amersham ImageQuant 800 biomolecular imager. This system is ideal for chemiluminescence, fluorescence, and colorimetric imaging of a wide variety of samples, including gels, membrane blots, multiwell plates, and petri dishes.